UCSF-Kaiser Department of Research Building Interdisciplinary Research Careers in Women's Health (BIRCWH) Program

ABSTRACT
This administrative supplement application proposes to add a fourth scholar to the University of California, San
Francisco (UCSF) and Kaiser Permanente Northern California (KPNC) Department of Research's Building
Interdisciplinary Research Careers in Women's Health (BIRCWH) Program. The program objectives are to:
1. Recruit a superb and diverse group of early-career women's health researchers;
2. Provide tailored training and mentoring on sex and gender influences in health and disease;
3. Build upon our existing program by targeting topics in women's health of public health importance;
4. Strengthen and integrate models of interdisciplinary research to develop researchers who foster
linkages across disciplines and institutions and excel in building team science; and to
5. Promote the prominence of women's health and the retention of investigators underrepresented in
clinical research by mentoring BIRCWH scholars and alumni in academic advancement and leadership.
The rationale of our program is that scholars' successful careers in women's health will transform biomedical
research and ultimately advance women's health in the US through sustained focus on the study of sex and
gender influences in health and disease. The program brings together mentors and advisors from 16 UCSF
departments and centers and from KPNC. The program design emphasizes interdisciplinary approaches to a
wide range of women's health issues. We will continue the program's initiatives in path-breaking research in
women's cancers; environmental health; mental health, addiction, and cognition; infectious diseases;
metabolism and bone health; and reproductive health across the lifespan, including Black maternal health, an
NIH priority. A multidisciplinary UCSF/KPNC Advisory Committee oversees the program in partnership with
leadership, including for the selection of new scholars. Our program is strengthened by mentoring teams that
cross disciplines and research methodologies.
Diverse scholars and faculty—in terms of fields of interest, background, training, race/ethnicity, and gender—
are a priority. We will strengthen our focus on supporting underrepresented scholars for this proposal, and
directly connect the fourth scholar to a network of our BIRWCH scholars and alumnae underrepresented in
medicine for ongoing peer and mentor support. We will also ensure additional resources, such as mentoring
from underrepresented faculty and UCSF and KPNC leaders on our Advisory Board. Our BIRCWH scholars
are supported for at least two years, receive tailored mentoring, and participate in training courses, program
seminars, progress assessments, and leadership development activities, often including alumnae. An array of
career development and training opportunities at the UCSF Clinical and Translational Science Institute (CTSI)
support our BIRCWH program. The career development path for each scholar is tailored to the specific
experience and mentoring that will most effectively support transition to independence. Our program evaluation
follows a conceptual framework of important domains to scholar career development, with survey measures
that assess scholar outcomes such as career trajectory, scientific productivity, and BIRCWH program
effectiveness for up to 10 years afterwards.

Public health relevance
Project narrative The UCSF-KPNC Building Interdisciplinary Research Careers in Women's Health (BIRCWH) Program offers mentored training to scholars to advance women's health in the U.S. through the study of sex and gender influences in health and disease. This proposal will directly strengthen career development of underrepresented scholars and those living with disabilities, enhance workforce diversity, and increase focus on significant public health issues. The program strengthens interdisciplinary research skills and trains women's health researchers for successful careers in team science focused on topics of public health importance, ultimately improving U.S. health outcomes.